Intranasal delivery of VGF-derived peptides in a preclinical model of Alzheimer's disease

Late onset Alzheimer’s disease (AD), the most common form of dementia, is characterized by memory loss and
a progressive decline in cognitive function. The Accelerating Medicines Partnership-Alzheimer’s Disease (AMP-
AD) program has supported systems biology analyses, with VGF (non-acronymic), a neurotrophin-inducible
protein and neuropeptide precursor, being one of the top ranked AD drivers (regulators) identified by several
groups. Notably, biomarker studies have consistently identified reduced VGF levels in the brains and CSF of
patients with AD, and have further demonstrated that VGF is also a strong candidate biomarker of AD
progression. Our recent published data demonstrate that VGF overexpression in hippocampus or chronic
intracerebroventricular (icv) infusion of the VGF-derived neuropeptides TLQP-21 or TLQP-62 (named by the N-
terminal 4 amino acids and length) reduces cortical and hippocampal amyloid deposition, microgliosis, and/or
astrogliosis, in a regionally-specific manner, and reduces cognitive impairment in the 5xFAD mouse amyloidosis
model. TLQP-21 activates the complement C3aR1 G-protein coupled receptor (GPCR), also implicated in AD
pathogenesis and expressed in the CNS on neurons, microglia, and astrocytes, while the antidepressant and
procognitive functions of TLQP-62 are dependent on BDNF/TrkB signaling. In this RO1 proposal, we request
support for preclinical studies that will optimize intranasal (IN) nose-to-brain therapeutic delivery of the VGF-
derived peptides TLQP-21 and TLQP-62 to mice, and will determine their efficacy in the 5xFAD mouse model of
amyloidosis and then subsequently in the PS19 tauopathy model to reduce neuropathology and the progression
of AD-like phenotypes. Our preliminary imaging data indicates that intranasal administration of Cy5-TLQP-21
and Cy5-TLQP-62 results in significant, rapid brain uptake. Aim 1 will determine regional uptake in the brain and
any systemic spillover of IN Cy5-conjugated peptides, using small animal imaging and western analysis of brain
and peripheral tissues. Aim 2 will verify retention of intact peptide in brain using Cy5- and biotin-conjugated
peptide quantification by western analysis, and will determine ‘target engagement’ in hippocampus and cerebral
cortex by IN peptide, including BDNF/TrkB/CREB and c-fos activation. Interim milestones include identification
of the optimal dose and dosing interval for IN peptide delivery based on quantification of regional peptide levels
in the brain, and the determination that signaling pathways known to be regulated by intra-hippocampal or icv
delivery of these peptides are activated by IN peptide. Aim 3 will utilize the most efficacious IN delivery schedule
identified to determine whether cognitive impairment and neuropathology in 5xFAD and PS19 can be reduced.
Lastly, longevity of intranasal peptide treatment effects will be tested, systemic toxicity will be assessed, peptide
modification(s) will be considered, and behavioral, biochemical, histological and large-scale genetics approaches
will be employed to measure relative peptide efficacy in reducing disease progression. These preclinical studies
will provide a firm foundation for future intervention using intranasal delivery of VGF peptide therapeutics in AD.

Public health relevance
Alzheimer’s disease, characterized by a progressive decline in cognitive function, is the most common form of dementia. Large-scale genomics studies have recently converged on VGF as a critical driver (regulator) in the signaling networks that underlie Alzheimer’s disease pathogenesis and progression in human patients, and data from our labs further demonstrate that VGF overexpression or intracerebroventricular administration of VGF-derived peptides to the 5xFAD mouse model reduces amyloid plaque load, microgliosis and astrogliosis, in the brain. The proposed studies will optimize intranasal nose-to-brain VGF peptide delivery, will determine whether these VGF peptides engage targets in the brain, and will investigate efficacy of intranasal peptides to rescue neuropathology and memory impairment in mouse models of neurodegeneration, providing a firm foundation for future translation of VGF therapeutics to human subjects with Alzheimer’s disease.